A Proteomic Comparison of Sporadic Early-Onset, Late-Onset, and Autosomal Dominant Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is commonly considered a disease exclusive to the elderly. While aging is the largest
risk factor for the development of AD, approximately 5 to 10 percent of AD develops in people younger than age
65. In most early-onset AD cases there is no clearly identifiable genetic mutation that causes the disease, and
therefore such cases have been termed sporadic early-onset AD (sEOAD). Compared to late-onset AD (LOAD)
or autosomal dominant forms of AD (ADAD), little is known about the pathophysiology of sEOAD. In contrast to
LOAD and ADAD, sEOAD more often presents with clinical syndromes that affect visual-spatial, language,
executive and behavioral cognitive domains, and on average has a more rapidly progressive course compared
to LOAD. Whether the underlying pathophysiology and biological pathway alterations, and biofluid biomarkers
that reflect these changes, are the same in sEOAD as those in LOAD and ADAD is unknown. Our previous brain
proteomic studies on LOAD through the Accelerating Medicines Partnership for AD (AMP-AD) have revealed
many different pathological changes in LOAD beyond amyloid-β and tau dyshomeostasis. The goal of this project
is to apply a similar proteomic approach to sEOAD to advance our understanding of sEOAD pathophysiology
and how it is similar or distinct from LOAD and ADAD pathophysiology. We hypothesize that sEOAD will have
more severe changes in mitochondrial, proteostasis, complement, and RNA-associated protein pathways
compared to LOAD and ADAD. We will leverage a multi-platform discovery proteomic approach to analyze
sEOAD and LOAD cerebrospinal fluid (CSF) and plasma to determine whether differences in EOAD brain
pathophysiology can be observed in biofluids, and how these changes are related between CSF and plasma
compartments. From our cross-tissue proteomic data we will assess which brain-linked biomarkers in sEOAD
are most predictive of cognitive decline. These studies will significantly increase our understanding of the protein
network changes that characterize sEOAD and how they are similar or unique to those observed in LOAD and
ADAD. Such knowledge will be critical to ensuring that therapies and biomarkers developed for LOAD are
applicable to those with early-onset forms of AD.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease can affect people younger than age 65, yet it is unclear whether the disease is different in middle aged people compared to older individuals. This research project aims to advance our understanding of the protein changes that occur in Alzheimer’s disease in people younger than age 65. Such knowledge is critical to ensure that diagnostic tests and therapies developed for Alzheimer’s disease are applicable to this younger population.